Circadian SCN-Liver Axis in the Neuroendocrine Response to Calorie Restriction

In mammals, the hypothalamic pacemaker clock synchronizes peripheral tissue clocks to temporally partition
oxidative and reductive metabolic pathways to align fuel utilization with nutrient availability. Yet how the circadian
clock in brain and peripheral tissues integrates nutrient state with transcription to promote energy conservation
and metabolic homeostasis during sleep and in nutrient scarce conditions remains obscure. An exciting clue as
to how nutrient signals control circadian transcription emerged from the discovery in our group and others that
nicotinamide adenine dinucleotide (NAD+) and the NAD+-dependent deacetylase SIRT1 regulate circadian
behavioral and mitochondrial rhythms through posttranslational modification of the core clock repressor PER2,
indicating that NAD+-SIRT1 controls clock cycles within both neurons and peripheral cells. Interconversion of
NAD+ with its reduced form NADH during redox reactions is dependent upon nutrient state. In new results
published after our first submission, we show that NADH accumulation in liver during healthful calorie restriction
inhibits SIRT1 and reduces daytime body temperature and oxidative metabolism. Surprisingly, reducing NADH
levels through hepatic transduction of the water-forming NADH oxidase Lactobacillus brevis (LbNOX) disinhibits
SIRT1 and augments oxidative cycles of metabolism and transcription. Further, our newly-generated PER2K680Q
acetyl-mimetic knockin mice, which are resistant to SIRT1-induced deacetylation, exhibit profound period
lengthening, while clock ablation in the suprachiasmatic nucleus (SCN) abrogates rhythmic feeding and
thermogenesis. We are now poised with innovative genetic tools and circadian protocols to dissect how the
circadian clock promotes energy constancy during sleep and in adaptation to calorie restriction at the level of the
liver (Aim 1) and hypothalamic pacemaker neurons (Aim 2). Aim 1 will specifically test the hypothesis that nutrient
sensing by the clock involves NAD(H)-SIRT1 signaling. We propose to dissect the role of redox state in clock
function and metabolism during sleep and calorie restriction by genetically manipulating NAD(H) levels using
LbNox in combination with hepatic clock ablation or PER2K680Q acetyl-mimetic knockin mice. Aim 2 will examine
the role of hypothalamic pacemaker neuron subtypes in synchronizing thermogenesis, feeding, and metabolic
rhythms with sleep and in the adaptive response to calorie restriction by utilizing an innovative combination of
CRISPR-Cas9 clock ablation, loss and gain of function studies, and projection-based chemogenetic manipulation
of pacemaker neurons. Collectively, our proposed studies will elucidate circadian mechanisms involved in
maintenance of energy constancy across the sleep-wake cycle and how clock adaptations contribute to health
benefits of hypocaloric diet.

Public health relevance
Project Narrative: A major function of the circadian system is to align feeding and metabolic cycles to optimize nutrient storage and utilization across the light/dark cycle, though how the clock senses changes in nutrient availability to maintain metabolic homeostasis throughout the day is not well-understood. The major goals of our proposed studies are (i) to dissect the mechanisms underlying the role of the clock at the level of liver and brain in maintaining energy constancy during fasting/sleep, and (ii) to dissect the molecular basis for nutrient sensing by the clock that underlies the physiologic adaptation to healthful calorie restriction. Results from the proposed studies will elucidate how the clock sustains the vital provision of energy to brain during sleep and how calorie restriction acts through the clock to improve health.